Structural variants and the locus of evolution

PROJECT SUMMARY
Mutation is the ultimate source of genetic and genomic variation and the relationship between mutation and evolution-
ary change is a fundamental question in biology. Mutations can occur as single nucleotide polymorphisms (SNPs) or
larger structural variants (SVs) like duplications, deletions and copy number variants. Molecular studies have focused
extensively on SNP variation but DNA sequencing technologies are increasingly demonstrating the prevalence and im-
portance of genomic SVs. The recency means that there is little understanding of SVs in evolution and few theoretical
predictions to guide empirical investigations. For example, organisms with holocentric chromosomes, characterized
by diffuse centromeres spread across the length of the chromosome, can have high rates of intrachromosomal
rearrangements and SVs segregating in populations. The sojourn time of a mutation fundamentally affects the
dynamics of natural selection and may differ for SNPs and SVs. Understanding the evolutionary significance of SVs
requires greater understanding of the ways in which population genetic forces of drift, selection and recombination act
on SVs, the long-term outcomes of SVs in genomes and the mechanisms that generate segregating SV mutations.
This application proposes to address these gaps in scientific understanding by addressing 3 questions:
1) What are the population genetics of SV mutations?
2) How do SV mutations accumulate to differences in genome size and content?
3) Does the frequency spectrum of SVs vary between organisms with holocentric and metacentric
chromosomes?
To answer these questions my lab group will pursue a synergistic set of theoretical and comparative genomic
projects. We will study a theoretical graph-based model of SVs and formulate a comprehensive population genetic
theory of SV evolution. We will use our theory to formulate predictions regarding SV evolution and test our predictions
by analyzing empirical genomic change in a phylogenetic comparative framework and studying the spectrum of
SVs in holocentric and monocentric organisms. My research program uses an innovative combination of theory
and comparative computational genomics to address fundamental evolutionary questions. The research proposed
here will result in exciting discoveries unlocking the rules of eukaryotic genome evolution.

Public health relevance
Project Narrative Mutations can be small single nucleotide polymorphisms (SNPs) altering a single DNA base or they can be larger structural variants (SVs) involving the duplication or deletion of large segments of DNA. SV mutations can underlie human diseases and disorders but we know little about the frequency with which SV mutations arise, the evolutionary forces that act on SV mutations, and how they influence evolutionary change. This work will improve the accuracy of model organism-based investigations of human diseases and developmental disorders by discovering the frequency with which SVs are generated in different populations, studying how population genetic forces act on SVs and examining how SVs diverge across the tree of life.